A comprehensive imaging solution for dense breast cancer screening and diagnostics

Project Summary
Our overarching goal in this project is the development and evaluation of a stand-alone breast cancer image
device that facilitates more rapid, effective, and definitive cancer detection and diagnosis in dense breast
women. The device being developed is based upon our proprietary Narrow-Beam Computed Tomography
(CT) technology—an image acquisition architecture that fundamentally differs from existing CT designs.
The key advantage of this technology is its ability to deliver three-dimensional images in high spatial
resolution that are nearly free of contamination from scatter, at low levels of dose deemed safe for breast
cancer screening applications, without any breast compression. The system’s unique ability to yield high
quality, fully tomographic (3-dimensional) spectral data makes possible the delivery of detailed, time-
based, diagnostic information that may allow for effective identification of malignant cancers in all women,
but specifically in women with dense breast tissue. The specific aims of this project include developing a
time-based image reconstruction to further increase the temporal resolution of the system without extending
required scan time. Validation of the developed methodology is through a hybrid 4D anthropomorphic flow
phantom developed collaboratively with our partner laboratory. Another focus of this project is gaining
insight into the clinical viability of our solution through a first in patient retrospective pilot study. Upon
completion of this project’s aims, we will have a device for large-scale in-patient prospective studies.

Public health relevance
Project Narrative Breast cancer is the common type of aggressive cancer among women. The widespread cancer screening has reduced the mortality of this disease. Nevertheless, the gains are highly dependent on the specificities of the breast anatomy. The breast imaging community is very aware of the limitations of mammography and breast tomosynthesis (limited angle x-ray tomography of the breast) in regard to breast cancer detection, especially in the dense and extremely dense breast women. As a result, additional breast imaging modalities are used with increasing frequency, but there is no standalone imaging modality for addressing the dense breast issue. Breast ultrasound solutions are used in various settings but are limited in that they augment mammography. Breast MRI solutions are effective but costly to acquire and maintain. Dedicated breast CT has been studied at several sites with promising results. However, the inherent shortcomings of the current renditions of breast CT have hindered its clinical impact. We have devised a new methodology of CT image acquisition (dubbed narrow-beam CT) with the specific aim of resolving the dense breast problem. Through the Phase I period of this Phase II project, we built and tested a prototype narrow-beam CT system. A final version of this modality is currently being assembled in the laboratory. This new R44 grant proposal seeks to develop the finishing touches on the necessary hardware, perform necessary advancements in software. In addition, we will perform a first-in-patient pilot study to gain insight about the viability of this solution through clinical comparisons between breast CT and mammography/tomosynthesis in non-contrast (screening) setting, and comparisons between contrast enhanced breast CT and contrast enhanced MRI in diagnostic settings.